Research Project 4: Mining human antibody responses to inform vaccine and therapeutic design

Abstract: This proposal embodies the development of an advanced platform for rapid identification,
characterization, and optimization of monoclonal antibodies (mAbs) to effectively combat nairoviruses,
hantaviruses, and paramyxoviruses. Our work is centered on comprehensive immune profiling of naïve and
convalescent donors, identifying and characterizing mAbs throughout disease progression. To identify mAbs, we
employ multivalent memory B cell sorting, Ig-Seq proteomics, naive B cell sorting, and antibody engineering
using eukaryotic display technologies. Our proposal includes a comprehensive study of immune responses to
catalog epitopes and immunodominance hierarchies, which will be instrumental in improving our understanding
of establishment and maintenance of prototypical protective humoral immunity to these viruses. This critical new
information will enable the design of next-generation vaccine candidates for these virus families. The second
aim focuses on the understanding of antibody-antigen interactions at the molecular level. This aim incorporates
high-throughput epitope mapping using state-of-the-art mammalian display technology, performed using deep
mutational scanning and epitope shuffling. In addition, we will explore potential viral escape mechanisms to
inform the design of broadly protective antibody cocktails. By combining cryo-electron microscopy, viral
mutational escape through forward genetics, and deep mutational scanning, we plan to visualize the escape
maps and understand how these viruses may evolve over time to avoid neutralizing antibodies elicited by
vaccines. The third aim is directed at optimizing mAbs for effective development and enhancing their protective
capabilities. Advanced machine learning algorithms and antibody engineering techniques will be used for
creating mAbs that are efficient to produce, stable, highly-affinity, and broadly protective. The algorithms will be
trained to predict and address potential sequence-based manufacturing and developability issues to optimize
mAb sequences for efficient expression and stability during production, purification, and storage. This aim
includes engineering bispecific mAbs and mAb candidates for serum stability, development of stable cell lines
during hit identification and optimization, and evaluation of virus neutralization and protective potential in relevant
animal models. The interplay of these three aims will facilitate a novel platform for rapid generation of high-
affinity, broadly protective, manufacturable, and serum-stable mAbs against prototypical viruses. This holistic
approach is expected to improve our ability to respond rapidly and effectively to emerging biological threats,
provide crucial information to the design of efficacious vaccines in projects 2 and 3, and refine a platform for
countermeasures development. Our collaborative research team is comprised of experienced scientists with
expertise in immunology, virology, antibody/protein engineering, and machine learning. The team has a strong
track record and is well-positioned to make significant contributions to virology, immunology, and vaccinology.
This project will contribute to the overall goals of the PROVIDENT consortium by developing tools for designing
vaccines and providing a scalable countermeasures platform for future threats.

Public health relevance
Please see Overall for Project Narrative.